Functional Connectomics Component - George

Abstract
The TSRI-ARC and others have identified numerous molecular changes and dysregulations of
specific neuronal circuits, including the extended amygdala, contributing to excessive alcohol
drinking in dependent animals. However, there is considerable evidence that such complex
behavioral states and associated behaviors are encoded throughout the brain in dozens if not a
hundred brain regions. Unfortunately, the functional connectivity of single-cell whole-brain
networks during alcohol abstinence is largely unknown because of technical limitations. The
Functional Connectomics component will bridge this gap using single-cell whole-brain imaging
of immediate-early genes to identify the network mechanisms associated with pharmacological
interventions (Specific Aim 1) and circuit-specific interventions (Specific Aim 2) that decrease
addiction-like behaviors during abstinence. The overarching hypothesis is that FDA-approved
medications and ARC-related experimental compounds candidates for the treatment of alcohol
use disorder normalize network modularity, deactivate the extended amygdala network, and
strengthen the cortical networks. We will also test the hypothesis that manipulations of the
lateral hypothalamus-infralimbic-amygdala pathway shown by other ARC components to
decrease addiction-like behaviors will also increase brain modularity and identify the specific
subnetwork mechanisms associated with these manipulations. The use of advanced
computational network analysis, including graph theory, machine learning frameworks, minimal
network analysis, and advanced network comparisons, will allow us to identify whole-brain
networks that predict behavioral states and identify repetitive patterns of connectomics changes
that predict the therapeutic effects of interventions that decrease addiction-like behavior.